Biological Mechanisms Core-RC-2

Resource Core 2 (RC2) Biological Mechanisms Core: Project Summary
The identification of the etiologies of frailty and age-related vulnerability remains a crucial challenge for
gerontological research. Key to this challenge are the development of a better understanding of the
underlying biological basis that contributes to frailty and the identification of key biological pathways for the
development of interventions that might help prevent or alleviate frailty and loss of independence. The goal
of Johns Hopkins Older Americans Independence Center (OAIC) Biological Mechanisms Core (RC-2) is to
enable the next generation of frailty-related etiological discovery and to promote the translation of these
discoveries into clinically relevant diagnostic, preventive, and treatment modalities. This core achieves this
through the provision of high-quality biological measurement expertise, technologies, and infrastructure
necessary to attain this goal. In order to comprehensively encompass the biological and measurement
expertise necessary to study frailty-related etiology, we have engaged a leadership team with considerable
biological and translational expertise as well as several internal consultants who bring crucial additional
expertise, mentorship for trainees, and infrastructure to RC-2. The specific aims of RC-2 are to: 1) provide
state of the art scientific expertise, infrastructure, and technology necessary to advance biological and
etiological research related to frailty, 2) provide access to biological samples from human subjects and from
animal models necessary to test hypotheses related to frailty, 3) facilitate the translation of biological
findings into interventions or prevention-focused clinical studies, 4) provide training, mentorship, and
guidance to promising junior investigators around biological mechanisms that impact frailty, and 5) provide
institutional and external visibility for RC-2 related science and activities. These visibility efforts will be
further facilitated by a novel Information Dissemination Core (IDC) as described in section 8. Our aims will
be accomplished through close communication between the core leaders and their laboratories, close
partnership with the other OAIC cores, and the engagement of expert consultants in the highly relevant
areas of mitochondrial measurement, metabolomics, mouse model development, nanotechnologies for
diagnostic purposes, and nanotechnology related to drug development. By providing these resources, RC-2
will foster high quality research that elucidates clinically relevant biological pathways that underlie frailty and
related interventions that hold promise to attenuate frailty, related conditions, and the loss of independence.